Oklahoma TRUST Access Hub

Project Summary/Abstract. The overarching goal for the Stephenson Cancer Center (SCC) Oklahoma (OK) TRUST ACCESS Hub is to enhance capacity for increasing cancer screening trials accrual and participation throughout Oklahoma, a highly rural state. Collectively, 85,000 persons aged 45 to 75 years receive healthcare at OK TRUST Affiliate Organization facilities located across the state. Specifically, OK TRUST will implement processes to: 1) Provide leadership and administrative support to conduct Cancer Screening Research Network (CSRN) trials across Affiliate Organizations in the Oklahoma catchment area and participate in shaping the emerging CSRN research agenda; 2) Expand access to and increase enrollment in cancer screening trials by offering the Vanguard study, and future studies, in participants’ home communities and healthcare facilities; and 3) Leverage SCC’s nationally recognized expertise in clinical trials to include regulatory and operational support for cancer screening trials offered in tribal, rural and urban locations statewide.

Public health relevance
Project Narrative. Cancer affects all populations, but Oklahoma, a highly rural state, has notably high cancer incidence and mortality rates. Many individuals from Oklahoma communities face daunting challenges in accessing cancer screening and diagnostic follow-up services. The SCC Oklahoma TRUST ACCESS Hub will bring recent advances in cancer screening to Oklahoma communities by increasing access to cutting-edge cancer screening trials.